Symptom Monitoring using Patient-Reported Outcomes to Optimize Medication Use (SyMPTOM)

PROJECT SUMMARY
For the more than 200,000 women who develop hormone receptor positive breast cancer yearly, endocrine
therapy for at least five years reduces cancer recurrence by nearly 50% and increases overall survival. Yet
almost half of patients prescribed endocrine therapy fail to take all their pills. Education and reminder-based
studies in this and other clinical settings have had disappointingly small effects on adherence, and more
complex interventions have proven difficult to sustain. In this proposal, we focus on the pain, menopausal, and
other symptoms that women describe as major barriers to endocrine therapy adherence. We have drawn on
two complementary sets of research findings: first, trials in chemotherapy settings recently reported that routine
symptom monitoring and management can improve a number of outcomes, including survival; and second,
research from non-oncologic chronic care settings has shown that a number of outcomes can be improved with
outreach to high-risk patients by nonphysician providers in between physician visits. We propose an
intervention targeting high-risk patients who already have poor adherence to endocrine therapy. In a
randomized study, we will routinely collect patient-reported symptom data from patients. Clinical pharmacy
teams will support patients to manage symptoms and address other barriers so they can continue daily
medications. The primary objective of the study is to improve adherence, with specific aims as follows: Aim 1:
Assess the impact of symptom monitoring and management with clinical pharmacist led follow-up (the
intervention) on patient adherence to oral endocrine therapy. We will assess the impact of a 12-month
intervention on adherence and evaluate adherence again at 24 months to assess intervention durability. Aim
2: Describe the impact of the intervention on symptoms. We will model the average trajectories of patient-
reported outcomes over time by study group. We will also model symptoms by adherence level since side
effects may increase if adherence increases. Aim 3: Explore the impact of the intervention on potential
mechanisms for improvement of adherence. We will use mediation analysis to examine the relationships
between the intervention and proposed mechanisms including 1) baseline symptom severity 2) self-efficacy to
manage medications and symptoms, 3) team communication with the patient, and 4) social support. If
successful, this study has the potential to improve care for thousands of women. Many newly approved
oncologic medications are oral agents, so this intervention would also be an important model for other
conditions and could inform the design of oncologic care delivery.

Public health relevance
PROJECT NARRATIVE For curatively treated hormone receptor positive breast cancer, taking 5-10 years of a daily oral endocrine therapy such as tamoxifen or an aromatase inhibitor cuts the risk of breast cancer recurrence nearly in half, yet nearly half of women taking endocrine therapy to prevent breast cancer recurrence do not meet minimum thresholds for adherence, often due to symptoms. We propose to test whether oncology teams can improve long-term oral oncologic medication adherence through better symptom monitoring and management.